CAV-1 in Jak/STAT Signaling, Lactation, & Breast Cancer

at the top of each pdnted page and each continuation page. Type density and size must conform to limits and specifications provided in the PHS 398 Instructions, RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page .......................................................... 1 2 Description,